Epigenetic Modifications of BDNF and trkB Genes Underlie Pain Plasticity

DESCRIPTION (provided by applicant): Although we are at the end of the Congressionally-declared Decade for Pain Control and Research, chronic pain continues to be a leading public health epidemic, affecting more than 50 million Americans and costing more than $165 billion per year in treatment expenses and lost work productivity. Of particular note are those patients with chronic diseases, such as cancer and HIV, who suffer from treatment-related pain that cannot be controlled with conventional analgesics. Treatment-related pain affects approximately 50% of these patients, depending on drug and dosing regimen, which translates into nearly 700,000 Americans per year. The predominant symptom is excruciating unremitting pain that is resistant to traditional pharmacological treatments. As therapeutics become increasingly aggressive and diseases become chronic, this becomes a risk/benefit issue; patients must choose between increased life expectancies and constant suffering with decreased quality of life. This decision is untenable, and thus, the crucial question that must be answered is how to prevent or reverse persistent disease treatment-related pain. Recent mechanistic studies have found that the development and persistence of neuropathic pain stems in part from central sensitization in the spinal dorsal horn. Much like memory formation in the hippocampus, central sensitization in the spinal cord produces pain hypersensitivity that is uncoupled from noxious input. More simply put, innocuous inputs produce long lasting pain hypersensitivity. Recently, we made the preliminary discovery that antiretroviral treatment produces up-regulation of Brain-derived Neurotrophic Factor (BDNF) in the mouse spinal dorsal horn, causing central sensitization (hyperexcitability of spinal dorsal horn neurons) and the development and persistence of nocifensive (pain) behavior. Reducing levels of BDNF expression in vivo reversed this phenotype. These data implicating BDNF in treatment-related pain suggest that BDNF may represent a new target for drug development. However, further studies to determine precisely how chemotherapeutic drugs alter BDNF expression and that of the BDNF receptor, tyrosine kinase receptor B (trkB) are crucial first steps. One likely possibility is via epigenetic regulation of BDNF and trkB gene expression. In support of this idea, we have shown that alterations in DNA methylation and histone modifications in promoter regions produce changes in BDNF gene expression that regulate the capacity for long-term memory formation. Thus, we hypothesize that complex epigenetic regulation of BDNF and trkB may produce gene dysregulation that is mechanistically linked to long-term chemotherapy-induced neuropathic pain. In addition, we posit that other genes, not previously linked with nociception, may undergo epigenetic regulation and we will examine this question using chromatin immunoprecipitation (ChIP) followed by high-throughput next generation sequencing (ChIP-seq). Results from these studies will have broad impact beyond treatment-related pain to improve our understanding of chronic pain persistence and the role for epigenetic modifications.

Public health relevance
PUBLIC HEALTH RELEVANCE: While potentially curative, the drugs used to treat patients with cancer and HIV/AIDS can produce a long- lasting pain. Occurring in some, but not all patients, this treatment-related pain complication is difficult to manage with conventional pain medications and so patients suffer with unrelieved pain. The results from the proposed studies may help us to understand treatment-related pain in more detail, and may provide new molecular targets for analgesic therapy. NARRATIVE While potentially curative, the drugs used to treat patients with cancer and HIV/AIDS can produce a long- lasting pain. Occurring in some, but not all patients, this treatment-related pain complication is difficult to manage with conventional pain medications and so patients suffer with unrelieved pain. The results from the proposed studies may help us to understand treatment-related pain in more detail, and may provide new molecular targets for analgesic therapy. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Millions of Americans with HIV and cancer suffer daily with neuropathic pain caused by the chemotherapeutic agents used to treat or cure the diseases. The predominant symptom is excruciating unremitting pain that is resistant to traditional pharmacological treatments. As therapeutics become increasingly aggressive and diseases transition from acute to chronic, this results in a risk/benefit issue; patients must choose between increased life expectancies and constant suffering with decreased quality of life. This decision is untenable, and thus, the crucial question that must be answered is how to prevent or reverse persistent disease treatment-related pain. Recent mechanistic studies have found that the development and persistence of neuropathic pain stems in part from central sensitization in the spinal dorsal horn. Much like long-term memory formation in the hippocampus, central sensitization in the spinal cord produces a molecular pain memory. More simply put, innocuous stimuli produce pain hypersensitivity. Recently, we made the preliminary discovery that antiretroviral treatment produces up-regulation of Brain-derived Neurotrophic Factor (BDNF) in the mouse spinal dorsal horn, causing central sensitization (hyperexcitability of spinal dorsal horn neurons) and the development and persistence of nocifensive (pain) behavior. Reducing levels of BDNF expression in vivo reversed this phenotype. These data, implicating BDNF in treatment-related pain, suggest that BDNF may represent a new target for drug development. However, further studies to determine precisely how chemotherapeutic drugs alter BDNF expression and that of the BDNF receptor, tyrosine kinase receptor B (trkB) are crucial first steps. One likely possibility is via epigenetic regulation of BDNF and trkB gene expression. In support of this idea, we have shown that alterations in DNA methylation and histone modifications in promoter regions produce changes in BDNF gene expression that regulate the capacity for long-term memory formation. Thus, we hypothesize that complex epigenetic regulation of BDNF and trkB may produce gene dysregulation that is mechanistically linked to long-term chemotherapy-induced neuropathic pain. Results from these studies will have broad impact beyond treatment-related pain to improve our understanding of chronic pain persistence. We will test this hypothesis via three specific aims: Aim 1. To test the hypothesis that changes in DNA methylation and chromatin structure in BDNF and trkB correspond with alterations in gene and protein expression in the spinal cord and examine the contribution of these changes to the development and persistence of nocifensive behavior and central sensitization in the mouse. In this aim, we will systematically examine methylation status, histone modifications and mRNA and protein expression levels of BDNF and TrkB in the mouse spinal dorsal horn prior to and at timepoints following administration of chemotherapeutic agents including stavudine (antiretroviral), oxaliplatin, paclitaxel, cisplatin, or combination (paclitaxel+cisplatin) compared with vehicle- treated mice. Results will be examined for correspondence with behavior changes and electrophysiological assessment of central sensitization in the spinal dorsal horn. In addition, we will manipulate DNA methylation status in vivo via administration of DNA methyltransferase (DNMT) inhibitors or genetic manipulation and examine the effects on pain behavioral and physiological phenotype. Aim 2. To test the hypothesis that susceptibility to develop persistent pain following chemotherapy administration partially or completely depends on the status of DNA methylation and local chromatin structure of BDNF and trkB in pre-clinical models and human subjects. Individual animals and patients demonstrate differential susceptibility to develop chemotherapy induced neuropathic pain and central sensitization. Might this be due to different baseline epigenetic states? In this aim, we will examine the methylation status, histone modification and mRNA expression levels of BDNF and trkB across several inbred strains of mice with differential sensitivity to develop chemotherapy-induced nocifensive behaviors and windup/central sensitization. We will interrogate DNA samples from patients treated with chemotherapy that did and did not develop dose limiting neuropathic pain to examine the methylation status of BDNF and trkB. These experiments will enable us to determine if the status of DNA methylation and chromatin structure can influence the development and persistence of treatment-related neuropathic pain. These studies might also allow the identification of a biomarker for susceptibility to neuropathy development and central sensitization. Aim 3. To examine the status of the epigenome in mice treated with chemotherapy versus mice treated with vehicle to elucidate new and novel gene candidates that contribute to behavioral phenotype and central sensitization. In the previous two aims, we take a candidate approach to the problem. Since it is unlikely that the epigenetic status of these two genes can fully explain the pain phenotype, in this aim, we will employ ChIP-Seq, which combines chromatin immunoprecipitation methods with high throughput, next- generation sequencing methods to examine the chromatin methylation status of the genome to identify biologically relevant loci in which changes in chromatin methylation correlates with pain phenotype.